GENE THERAPY FOR THE TREATMENT OF RECURRENT GLIOBLASTOMA MULIFORME

This study will evaluate the safety and efficacy of in vivo gene transfer of the herpes simplex thymidine kinase (HSV-Tk1) gene using vector- producing cells in patients with recurrent glioblastoma.